Mechanical Load Effects on Cardiac Function and Heart Diseases

Significance: In every heartbeat, cardiac muscle cells generate contractile force to pump blood into circulation
against a mechanical load. Cardiomyocytes also sense load changes and adjust the contractility to maintain
cardiac output. Excessive overload in pathological conditions leads to heart diseases such as arrhythmias and
heart failure. However, fundamental knowledge gaps still exist in the molecular and cellular mechanisms of
mechano-transduction in cardiomyocytes, and therapeutic treatments for mechanical stress associated heart
diseases (e.g., hypertension induced arrhythmias and heart failure, DCM, HFpEF) are severely limited to date.
Innovations: Previous experiments using load-free cardiomyocytes largely missed mechanical load effects on
regulating cardiomyocytes. We will develop an innovative Cell-in-Gel-TR technology to control mechanical load
at the single-cell level. Our studies reveal that the mechanical load on the cell during contraction can feedback
to regulate the 3 dynamic systems in excitation-Ca2+ signaling-contraction (E-C) coupling; closing these
feedback loops enables the cardiomyocyte to autoregulate E-C coupling in response to load changes. This
conceptual innovation will be explored in our R35 research to understand how mechanical load affects
cardiomyocyte function and heart diseases. Research Plan: The central theme of my research is to elucidate
how the 3 dynamic systems in E-C coupling feedforward and feedback to control the heart function as a
dynamically regulated smart pump. In R35, we will expand and deepen our research beyond the 2 R01s to do
multi-scale systematic studies of the mechano-transduction mechanisms and functional consequences. (1)
Molecular level study to decipher mechano-chemo-electro-transduction (MCET) pathways, identify the key
players, and determine molecular mechanisms. (2) Cell level study to investigate how mechanical load
regulates the dynamic systems of excitation-Ca2+ signaling-contraction coupling. (3) Heart level study to
probe how mechanical load regulates the intact heart function. (4) Study of heart diseases to understand
why/how pathological overload leads to cardiac remodeling, arrhythmias, and heart failure. These 4 parts are
designed to inform and enhance one another to provide a comprehensive view on how mechano-transduction
pathways work at molecular level, integrate at the cell level, and manifest to the heart’s ability to autoregulate
contractility in response to mechanical load changes in health and diseases. Capability and Adaptability: The
strength of my research stems from interdisciplinary approach. The history of my research shows a strong
track record in developing new technologies by combining rigorous methods in physics, chemistry, and biology.
In R35, I will continue developing innovative solutions and to use cutting-edge technologies to achieve the
transformative research goals. Expected Outcome and Impact: The research outcome will shift the paradigm
of cardiac E-C coupling to Autoregulatory Model, which will open new conceptual framework for understanding
how mechanical load affects heart diseases and help identify molecular targets for developing new therapies.

Public health relevance
NARATIVE In every heartbeat, cardiac muscle contracts against a mechanical load to pump blood into circulation to meet the body’s demands. Pathological overload leads to cardiac dysfunction and heart diseases. The proposed research will develop innovative technology to investigate the cellular and molecular mechanisms underlying load-induced cardiac arrhythmias and heart failure. The results will provide new therapeutic strategies for treating high blood pressure associated heart diseases such as arrhythmias and heart failure.